PHARMACOKINETICS OF TRANSFUSED VW FACTOR &FVIII IN VW DIS.

The aim of this project is to test the hypothesis that von Willebrand factor must be present in order for Desmopressin (DDAVP) releasable FVIII to be stored in vivo.